Applying Human Factors and Mathematical Modeling Approaches to Prevent Transmission of High-Consequence Pathogens

? DESCRIPTION (provided by applicant): The purpose of this proposal is to translate basic, epidemiologic, and technologic discoveries into new strategies to prevent healthcare-associated transmission of Ebola and other high-consequence pathogens. Healthcare-associated transmission of high-consequence pathogens such as the Ebola virus, SARS coronavirus, MERS coronavirus, novel respiratory pathogens, multidrug resistant bacteria, and Clostridium difficile poses a significant risk to patients, families, and healthcare workers (HCWs), leading to morbidity and mortality and dramatically increased healthcare costs. Recent experience with Ebola has shown that current infection prevention strategies may be inadequate to prevent transmission of high-consequence pathogens in healthcare settings. Using our broad experience and expertise and our history of successful collaboration, we propose a multifaceted and innovative framework integrating infection prevention, human factors engineering, and mathematical modeling approaches to address knowledge gaps in current infection prevention methods and to develop new interventions to prevent the transmission of high-consequence pathogens in healthcare settings. We hypothesize that: 1) self-contamination of HCW while doffing personal protective equipment (PPE) can be prevented by elucidating risk factors for HCW self-contamination and designing effective risk mitigation strategies to prevent HCW self-contamination events, 2) pathogen transmission from environmental sources can be effectively prevented by elucidating specific risk factors in environmental service (EVS) worker training, communication, culture and processes and designing effective interventions to optimize environmental cleaning and disinfection, 3) mathematical modeling will improve understanding of how resistance mechanisms impact transmission routes of carbapenem-resistant Enterobacteriaciae (CRE) in healthcare settings and the effectiveness of contact precautions for the prevention of CRE transmission. We will apply human factors and mathematical modeling (T0) approaches to gather data on risk factors and potential failure modes that contribute to pathogen transmission during HCW PPE doffing, EVS cleaning and disinfection of the environment, and the care of patients who are colonized or infected with CRE. We will then use the identified risk factors and epidemiologic transmission data to develop (T1), implement (T2) and assess new strategies within a large tertiary care hospital and across a health system of hospitals (T3). In addition to our expertise in infection prevention surveillance, intervention trils, and antimicrobial stewardship, in this proposal we demonstrate our capacity to integrate distinct scientific disciplines and introduce novel applications of evidence-based risk mitigation strategies to expand the science of infection prevention. The findings from this proposal will inform CDC guidance for frontline HCWs by providing concise and practical, evidence-based recommendations to prevent pathogen transmission in order to reduce harm to patients and healthcare workers.

Public health relevance
PUBLIC HEALTH RELEVANCE: This grant proposes several studies to improve the safety of patients and healthcare workers in the hospital. We will evaluate the best ways for healthcare workers to wear personal protective equipment to prevent self-contamination with and spread of infectious pathogens. We will explore the best ways to ensure the hospital environment is clean to prevent the spread of infectious pathogens to patients and healthcare workers.